Defining the gene regulatory roles of non-coding variants in the pathogenesis of autism

ABSTRACT
In this Predoctoral Fellowship proposal, I will be trained for a future as a physician-scientist with my own
independent research program at the interface of genomics, computational biology, and neuroscience.
During my MD/PhD training, I will be co-mentored by two physician-scientists, Drs. John Greally (Medical
Genomics) and Pablo Castillo (Neurology), addressing a question that is timely with the imminent widespread
use of whole genome sequencing (WGS) in clinical diagnostics – how do we interpret variants in the non-
coding majority of the human genome when a patient presents with a medical problem?
I will focus on autism, as a condition that represents a substantial proportion of patients seen by medical
genetics services, for which there is extensive WGS information from thousands of families. Despite this wealth
of research sequencing, only a small minority of individuals with autism receive a positive outcome of
diagnostic exome or WGS. I propose that the currently limited diagnostic success rates are mostly due to our
inability to interpret pathogenic variants in the non-coding majority of the genome of these patients. By
improving our insights into non-coding variants, we will be able to offer diagnostic information to many more
families seeking answers than currently.
My strategy is to focus on de novo variants (DNVs) in offspring with autism born to unaffected parents. My
hypothesis is that DNVs can be pathogenic when they occur in the cis-regulatory regions of cell types
mediating autism. The project is therefore based on a computational genomics foundation, using WGS and
DNV calls from large datasets from thousands of families who have a member with autism. In my preliminary
data, I show that DNVs in individuals with autism are enriched at cis-regulatory loci in glial and neuronal cells in
particular, and at genes known to be causative for autism. In my project, I will test these associations more
rigorously, and will define a high-confidence set of DNVs for functional testing.
Two types of functional testing will be performed. One will test whether the DNVs alter molecular genomic
properties, including chromatin accessibility and gene expression. The second will test the physiological
properties of the cells. To generate the appropriate cells for testing, I plan to use induced pluripotent stem cells
(iPSCs) that are in vitro differentiated to GABAergic neurons and astrocytes. By performing CRISPR-mediated
genomic editing in the iPSCs, I can generate cells with the candidate pathogenic DNVs, and test whether they
have effects on cellular properties like dendritogenesis, synaptogenesis, and electrophysiology, increasing the
confidence that these DNVs have pathogenic effects.
I will have the privilege of getting training in sophisticated computational, stem cell and neuroscience
techniques, under the guidance of two leaders in their fields, as part of a comprehensive training plan that will
equip me to become the independent physician-scientist I aspire to be in my career.

Public health relevance
NARRATIVE In our group’s CSER NYCKidSeq project, we found the diagnostic success rate for children with autism to be only ~25% despite performing whole genome sequencing. Our preliminary studies for the current proposal have revealed de novo variants in children with these conditions to be enriched in the cis-regulatory regions of glial and neuronal cells, near genes implicated in these phenotypes, defining candidate pathogenic non-coding variants. My project will test these de novo variants for their molecular regulatory and cellular effects, combining chromatin and transcriptional studies and neural cell characterization in GABAergic neurons edited to introduce these variants, the foundation for improving our ability to understand the genetic causes of children with autism.